Paracrine actions of fibroblasts promote pathologic cardiac myocyte remodeling in Duchenne muscular dystrophy

PROJECT SUMMARY: The long-term goal of our research is to improve our understanding of the pathologic
mechanisms of Duchenne muscular dystrophy (DMD) and to leverage that knowledge to advance therapeutics.
Progress in treating respiratory insufficiency and other complications of muscle deterioration has led to cardiac
disease emerging as a principal cause of morbidity and mortality in DMD. Consequently, there is a critical need
to identify the specific pathogenic mechanisms that promote DMD-related cardiac disease so that targeted
therapeutics can be developed. The complex pathology initiates with mechanically compromised myocytes but
is intertwined with secondary defects that contribute importantly to disease progression. Fibrosis is one of the
earliest clinical manifestations of cardiac involvement in DMD occurring prior to ventricular dysfunction indicating
the presence of activated fibroblasts early in the progression of pathology. Fibroblasts produce extracellular
matrix that comprises fibrotic scar, but it is not known whether they possess other maladaptive functions that
affect disease progression. Our preliminary findings now show that fibroblast growth factor (FGF) 23 is greatly
increased in cardiac fibroblasts of mdx mice, a genetic mouse model of DMD. Elevated FGF23 is remarkably
associated with important clinical events related to cardiovascular disease and mortality in patients with renal
disease and in the general population. FGF23 is a hormone that mostly works in cooperation with its co-receptor
Klotho, but can also stimulate pathological signaling in atypical cellular targets. FGF23 exerts pathologic effects
on cardiac myocytes by binding to FGF receptor (FGFR) 4 independent of Klotho, which is not expressed in the
heart. Our central hypothesis is that dystrophic cardiac fibroblasts exert paracrine effects on cardiac myocytes
via FGF23, thereby activating FGFR4 to promote cardiac disease in DMD. Our preliminary findings showing that
Klotho is cardioprotective in mdx mice strongly supports our hypothesis that FGF23 signaling contributes
importantly to cardiac remodeling. The central hypothesis will be tested by pursuing two comprehensive specific
aims. In Aim 1 we will test whether FGF23 is a paracrine factor produced by cardiac fibroblasts that promotes
dystrophin-deficient cardiac pathology and functional defects using a conditional genetic approach combined
with ex vivo cell culture experiments. In Aim 2 we will determine whether FGFR4 activation in cardiac myocytes
affects dystrophin-deficient cardiac remodeling and function using complementary loss-of-function and gain-of-
function genetic approaches. The proposed research is innovative because it is predicted to show that fibroblasts
exert regulatory effects on cardiac myocytes and establish FGF23/FGFR4 signaling as a novel pathogenic
mechanism of DMD. This contribution is significant because it is expected to provide strong mechanistic
justification for modulating FGF23/FGFR4 as a therapeutic target to treat DMD.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because Duchenne muscular dystrophy (DMD) causes muscle wasting, heart disease, and ultimately death. In this application, we will test a novel mechanism through which cardiac fibroblasts produce FGF23 to promote cardiac myocyte remodeling and functional defects in DMD hearts. The proposed research is relevant to NHLBI’s mission to identify specific pathogenic mechanisms that promote cardiomyopathy for the development of targeted therapeutics to preserve heart function so that patients can live longer and more fulfilling lives.